Monocyte and Macrophage Functional Evolution in Kidney Transplantation

Access to kidney transplantation as a cure for end-stage kidney disease is severely limited by donor organ
shortage. Exacerbating this shortage is the need for re-transplantation resulting from (1) early graft failure due
to poorly controlled alloimmunity; (2) late graft failure due to progressive organ fibrosis and occlusive
vasculopathy, two characteristics of chronic allograft nephropathy (CAN). Our preliminary studies from murine
models suggest that following organ anastomosis in kidney transplantation, the temporal process of initial
recipient monocyte infiltration followed by their ensuing differentiation to pro-inflammatory macrophages and
later macrophage maladaptive response to injuries plays a significant role in promoting alloimmunity and CAN.
Specifically, following the initial recipient monocyte infiltration, a monocyte cell-surface receptor tyrosine kinase
called AXL determines the ability of the infiltrating monocytes to differentiate to pro-inflammatory macrophages
and promotes alloimmunity. Consequently, inhibiting AXL early post-transplantation significantly prolongs
rejection-free allograft survival. Later, in response to injuries such as ischemia, a macrophage intracellular
protein called Allograft Inflammatory Factor 1 (AIF-1) determines their maladaptive response to ischemia and
promotes kidney fibrosis. Consequently, inhibiting AIF-1 during kidney ischemia significantly reduces long-term
kidney fibrosis. These observations led us to hypothesize that in kidney transplantation, AXL determines early
macrophage differentiation and function, whereas AIF-1 determines late macrophage response to injury. Thus,
a potential therapeutic opportunity is to sequentially block AXL and AIF-1 in kidney transplant recipients to (1)
inhibit early alloimmunity and (2) prevent late kidney fibrosis. In this new R01 application, we propose two
specific aims that will: (1) determine mechanisms of AXL in early post-kidney transplant period on promoting
alloimmunity. This aim will also determine extracellular and intracellular AXL signaling partners, and test clinical
values of murine findings in human monocyte cell lines; (2) determine mechanisms of AIF-1 in late post-kidney
transplant period on promoting maladaptive response to injuries and allograft fibrosis. This aim will also
determine AIF-1 signaling components that control kidney resident macrophage functional outcome, and test
clinical values of murine findings in human cell lines. Our experienced team of investigators include the PI
Dr. Luo, an expert in transplant immunobiology who will direct all immunological studies in murine kidney
transplant models, and the co-I Dr. Privratsky, an expert in acute and chronic kidney injury models who will direct
all studies of post-kidney transplant injuries and measurement of long-term kidney allograft fibrosis and function.
Our ultimate goal is to identify new temporal and pathway-specific targets for modulating macrophage functions
post-kidney transplantation. These studies will pave the road for future designs of macrophage-targeting
therapeutics for enhancing kidney allograft survival, thus reducing re-transplantation need.

Public health relevance
Donor organ shortage in kidney transplantation can be greatly mitigated by effective control of early alloimmunity and late organ fibrosis. Our preliminary studies suggest that recipient monocytes and macrophages play critical roles along the temporal line of this process. The overall goal of this proposal is to identify novel time-specific and pathway-specific targets for modulating recipient monocyte and macrophage functions post-kidney transplant, and ultimately pave the road for future designs of therapeutics for enhancing long-term kidney allograft survival.